Multimodal control of mitochondrial energetics to shape biological aging

The mitochondrial protonmotive force (PMF) is an electrochemical gradient across the inner mitochondrial
membrane that powers ATP synthesis and other mitochondrial signaling. PMF is naturally variable under
different situations, and can depend on nutrient status, cell or tissue type, and many other factors. Importantly,
evidence suggests that PMF declines with age. This observation holds from yeast to mammalian tissues.
However, it is still unclear whether this decline is a cause or a consequence of aging phenotypes. We show that
PMF declines with age in C. elegans and human cells and that Dietary Restriction (DR), a well-characterized
longevity intervention, prevents this loss. Furthermore, loss of PMF negates the effects of DR on C. elegans
longevity, further suggesting that PMF is a fundamental regulator of biological aging. This proposal aims to test
and fully characterize how PMF is a determinant of three different, but related, longevity paradigms: normative
aging, DR, and hypoxia signaling. DR is a reduction in caloric intake without causing malnutrition that results in
longevity. Hypoxia and signaling through hypoxia-inducible factor (HIF) extend lifespan and promotes health in
different models. Interestingly, while DR seems to preserve PMF, hypoxia treatment decreases PMF acutely.
These opposite effects on PMF in two different paradigms that extend lifespan must be investigated
mechanistically. Lack of tools to specifically modulate PMF in isolation in living tissue or intact organisms is a
critical gap in understanding how mitochondria regulate aging. This proposal aims to leverage what is known
through DR and hypoxia signaling to study new, conserved mechanisms of metabolic decline with age in models
of C. elegans longevity and human cell senescence. Until recently, there were no means to experimentally
increase PMF in isolation from other aspects of metabolism and physiology. PMF can now be isolated as a single
variable through optogenetics, the use of light-sensitive proteins to increase or decrease transmembrane
electrochemical gradients in vivo. Mitochondrial optogenetics allows us to control mitochondria directly leaving
other metabolic pathways intact. We propose that preserved mitochondrial energetics is a common causal
factor for both DR-mediated longevity and hypoxia signaling. We will test our models using cutting-edge
optogenetic techniques in parallel C. elegans and cellular models, which will ensure rigorous results and efficient
pathways for translation of our findings. We will test how PMF complements DR in animals and at the cellular
level, as well as how PMF interacts with hypoxia and HIF-mediated lifespan extension. We will further test how
well-characterized nutrient sensing signaling is regulated by PMF to cause longevity. New insight into how the
PMF specifically controls aging and longevity signaling will be an important investigation into the efficacy of
targeting metabolism for protection against disease in humans. Understanding the fundamental parameters of
metabolism and PMF in both worms and human cells will offer novel insights into what we already know, and
will pave the way for discovering new mechanisms of longevity downstream of mitochondrial PMF.

Public health relevance
Cellular hallmarks of aging can be manipulated through metabolism to modulate tissue aging and lifespan in model organisms. How mitochondria specifically contribute to the related longevity interventions of dietary restriction and hypoxia signaling remains unknown. Using novel optogenetic technology to gain a unique perspective, we will functionally dissect the molecular mechanisms of mitochondrial control over aging to extrapolate to general principles of cellular and organismal longevity.